The Role of RFX6 in Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is a devastating and chronic autoimmune disease that affects 0.5% of the US population.
Strategies for targeted induction of immune tolerance promise to produce a durable cure for T1D. However,
these approaches rely on knowledge of specific molecular targets of autoimmunity. INS, GAD2, and other known
autoantigens are the current gold-standard biomarkers for T1D, but the prevalence of ‘autoantibody-negative’
sporadic and immunotherapy-associated cases suggests that there are additional, unknown causal antigens in
T1D. Thus, high-throughput antigen discovery represents a critical next step to enable antigen-specific re-
establishment of immune tolerance in T1D. In preliminary work, I adapted a proteome-wide phage display
assay to identify antigenic targets of human serum autoantibodies. I applied this approach to sera from a cohort
of patients with Autoimmune Polyendocrine Syndrome Type 1 (APS1), with the rationale that (i) APS1 patients
have a high incidence of T1D and (ii) APS1 patients make high affinity antibodies, increasing the sensitivity of
my assay to discover novel autoantigens. Strikingly, I found that many APS1 patients exhibited a strong
autoantibody response to RFX6. As RFX6 is expressed specifically in pancreatic islets and has been implicated
in congenital cases of diabetes and intestinal pathology, this discovery motivates a mechanistic investigation of
the role of RFX6 in pancreatic autoimmunity. My central hypothesis is that RFX6 autoimmunity is sufficient to
cause diabetes and that RFX6 is a previously unknown autoantigen in sporadic T1D. In my first aim, I will use
mouse models to test the causal relationship between anti-RFX6 immune response and pancreatic pathology,
including overt diabetes. In my second aim, I will determine whether T1D patients mount an immune response
to RFX6. Specifically, I will test for RFX6 autoantibodies in sporadic T1D patients, as well as in autoantibody-
negative and immunotherapy-induced diabetes where there is a pressing need for antigen discovery. Finally, I
found in preliminary analyses that RFX6 may exhibit non-canonical regulation in the thymus: the pattern of RFX6
expression does not match that of classic tissue-specific autoantigens in the thymic epithelium. Therefore, in my
third aim, I will dissect the pattern and regulation of thymic RFX6 expression. Results from this aim will have
broad implications for the immunobiology of central tolerance, and more specifically, may elucidate mechanisms
of loss of immune tolerance in the setting of autoimmune diabetes. Together, these aims will definitively
determine the role and spectrum of immune response to RFX6. In the longer term, the goals of this project are
to establish an actionable clinical biomarker, as well as to expand the autoantigen spectrum in T1D to enable
improved specificity of future antigen-specific therapeutic approaches.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) is a common autoimmune disease which represents an enormous public health burden in terms of morbidity, mortality, and health care costs. The aberrant immune response in T1D targets and destroys insulin-producing cells of the pancreatic islets, resulting lifelong requirements for endogenous insulin, but the molecular targets of this response remain incompletely characterized in both sporadic and immunotherapy-associated type 1 diabetes. This proposal will determine the spectrum and role of T1D immune response to RFX6, a novel candidate autoantigen, with the goal of expanding the spectrum of T1D-associated antigens for diagnostic or predictive clinical utility as well as for improved biological understanding of T1D pathogenesis.